Defining the role of cytomegalovirus in glioblastoma therapies

Summary:
Glioblastoma (GBM) is an incurable brain tumor for which improved therapies are badly needed. There are
roughly 10,000 cases diagnosed in the US each year, and median survival is ~14 months. Evidence has been
accumulating over recent years linking cytomegalovirus (CMV) to GBM and other cancers. However, the role
of CMV in GBM remains poorly defined. CMV is a prevalent virus in humans, where it resides lifelong in a latent
state but can be reactivated under certain conditions. Several clinical trials targeting CMV using diverse
approaches including immunotherapies and the anti-viral drug valganciclovir have shown very promising
responses in GBM patients, but the underlying mechanisms are not clear. To improve our understanding of this
area we have developed an immunocompetent murine model of intracranial GBM grown in the context of a
systemic latent CMV infection. This consistently leads to significantly shortened survival compared with mock
infected controls in multiple distinct murine GBM models. These effects can be reversed by treatment with anti-
viral drugs.
The goal of this study is to investigate the role of cytomegalovirus in therapeutic resistance in glioblastoma,
building from our parent RO1 to design new combination approaches. As part of her PhD studies in the lab of Dr
Lawler, Jasmine Clark will: 1) Identify anti-viral drugs for the most effective combination with standard of care
(chemoirradiation), 2) investigate the role of altered vasculature/blood tumor barriers in therapeutic resistance,
and 3) find molecular mechanisms involved in mediating resistance, using our mouse and human models of
glioblastoma with CMV. Our goal is to develop improved therapeutic combinations.

Public health relevance
Narrative: Glioblastoma is a devastating brain cancer with no effective treatments. Data from our lab and others suggests that cytomegalovirus, which is widespread in human populations, has an impact on tumor growth and patient outcomes. The goal of this study is identify mechanisms underlying therapeutic resistance caused by cytomegalovirus, and to design new and more effective approaches.